Project 2

ABSTRACT – ALLFTD2: PROJECT 2
Approximately 70% of FTLD cases are sporadic (s-FTLD) and have no clear genetic or other identifiable cause.
Like familial FTLD (f-FTLD), s-FTLD is uniformly fatal and there are no approved treatments. The most common
s-FTLD syndrome is sporadic behavioral variant frontotemporal dementia (s-bvFTD), accounting for at least half
of all FTLD cases (including familial). Over the past five years, numerous disease-modifying drug development
programs have begun for f-FTLD, but none in s-bvFTD. This is because the underlying pathology and biological
mechanisms of disease are currently unknowable in most s-bvFTD patients during life. Moreover, the limited
tools to measure clinical features of disease and biomarkers outside expert tertiary referral centers leads to
delayed diagnosis, often past the stage where many disease-modifying strategies would be predicted to be
effective. This further complicates biomarker development and clinical trials due to the difficulty in obtaining high-
quality longitudinal data at quarterly intervals that would be examined in 12-18 month trials because travel to
research centers is a major barrier to data collection. The overall goal of this renewal project is to advance the
ability to conduct precision s-bvFTD and other s-FTLD clinical trials, by building molecular pathology-specific
disease progression models and more efficient assessment tools, leveraging advances that were made in f-
FTLD during the current ALLFTD cycle. During the current ALLFTD cycle we built Bayesian disease progression
models of the changes in biomarkers and clinical outcomes from presymptomatic through fully symptomatic
disease in f-FTLD-TDP (C9orf72 or GRN) and f-FTLD-tau (MAPT). We also developed and validated a mobile
smartphone app (mApp) and identified new candidate fluid biomarkers for FTLD-tau and -TDP in CSF and
plasma using novel unbiased proteomic techniques. For this proposed project, we will leverage these advances,
as well as new plasma extracellular vesicle (EV) biomarker measures to enable precision s-bvFTD trials. This
research project will develop fluid biomarkers for diagnosis and prediction in s-FTLD pathologic subtypes and
develop remotely collected digital assessments tailored for use in symptomatic s-FTLD syndromes. Importantly,
the project will also build s-bvFTD±ALS disease progression models (DPMs) from more frequently collected
data, informed by f-FTLD DPMs that will be critical for future biomarker discovery and improving early diagnosis.
By accomplishing these goals, we will have a new set of tools to diagnose and monitor s-FTLD patients that will
be useful both for clinical care and decentralized clinical trials that will be more feasible for the rare and
geographically dispersed populations who are recruited for s-FTLD clinical trials.